Core 1: Shared Resource Core (LCRSRC)

Linguistic and Cultural Responsiveness Shared Resource Core (LCRSRC)
The CCNY-MSK Partnership continues to grow the LCRSRC for this next Partnership cycle, to respond to the tremendous need to reduce cancer incidence and improve outcomes, and to leverage the great strengths, expertise, and tools of the U54 partners in this area. The LCRSRC’s goal is to provide linguistic support to the U54 Partnership Cores (Research Education, PCORE), Research Projects, and Working Groups (Immunotherapy, Biomedical Engineering, Health Policy, Social Influences and Health), and to build the capacity of U54-connected researchers and community members to reduce differences in cancer outcomes by providing linguistic support for translational research, outreach, education, and navigation. This crucial work leverages the strengths of the CCNY Department of Classical and Modern Languages and Literatures, the CCNY Grove School of Engineering, and the MSK Language Initiatives Program to support the U54.The specific aims of the LCRSR are: 1) to provide research consultation support and training in the selection and/or design of specific linguistically tailored quantitative survey tools, research study materials, educational materials, and practices for the U54 Research Projects, PCORE, and Research Education cores; 2) to assist CCNY, MSK, and community U54 investigators in the design, implementation, and analysis of qualitative research: to provide multilingual facilitation for, and to assist in the translation and transcreation of, focus groups, key informant discussions, and in-depth interviews; 3) To enable U54-linked studies and programs to utilize remote simultaneous medical interpreting (RSMI) (UN-style interpreting) to enable seamless communication between community members, patients, researchers, and PCORE, including for precision prevention/medicine and immunotherapy (a) to utilize this resource to help enable MSK Integrated Mutation Profiling of Actionable Cancer Targets (IMPACT) genomics studies to engage patients who speak English less than very well at community cancer centers and facilitate genetic testing and shared decision making, (b) to utilize RSMI to help engage community members in clinical trials, precision screening and prevention, and immunotherapy education, services, and studies, (c) to continuously monitor the promise of Artificial Intelligence (AI), e.g., deep learning and Large-Language Models (LLMs), as a medical Interpretation resource, with its potential efficiencies of scale and capacity for almost unlimited dissemination, and 4) to support the implementation of the CCNY Minor/Major in Medical Interpretation and Translation, to give bilingual CCNY students the skills to provide interpretation and translation services for cancer outreach, education, service delivery, and research, and to further build the LCRSRC capacity in these areas. The LCRSR will improve the way that translational cancer research activities and services reflect our surrounding communities, our city, and ultimately, through model dissemination, the nation.